Use of an electronic frailty index and biomarkers of aging to predict adverse outcomes and facilitate early identification of frailty in a cohort of persons aging with HIV

Project Summary/Abstract
National Institute of Aging Grant P30-AG-21332 (Project End 30 June 2023)
Principal Investigator: Stephen Kritchevsky, PhD
Since 1992, the Wake Forest Older Americans Independence Center (WF OAIC) has cultivated
investigators and expertise to develop and test new interventions to improve physical function
and prevent age-related disability. We have refined translational approaches that integrate
relevant disability and functional measures, behavioral and cognitive science, biostatistics,
genomics, muscle and adipose tissue biology, animal models including non-human primates,
biomarkers, state-of-the-art imaging modalities, and basic, clinical and populationbased study
designs. This grant cycle builds on the WF OAIC’s well-developed infrastructure and strong
track record of fostering collaborative, high-impact, translational science and earlycareer
investigator success through a coordinated, multi-disciplinary team approach focused on its
mission: To promote the health and independence of older adults. The WF OAIC activities are
guided by its scientific theme: Integrating pathways affecting physical function for new
approaches to disability treatment and prevention. This theme emphasizes common, age-
related, rather than disease-specific disability pathways so that discoveries and strategies can
be applied to older adults with and without a variety of chronic diseases and in differing contexts
of care. It also provides a framework to coordinate research activities across all Center facets.
The WF OAIC will provide leadership, resources and infrastructure to achieve four
programmatic aims: 1. Discover new pathways contributing to age-related declines in physical
function and disability risk; 2. Develop, evaluate and refine strategies for disability prevention
and treatment; 3. Translate proven strategies beyond traditional research environments; and 4.
Train the next generation of research leaders focused on disability treatment and prevention.

Public health relevance
Narrative Summary National Institute of Aging Grant P30-AG-21332 (Project End 30 June 2023) Principal Investigator: Stephen Kritchevsky, PhD Please see project abstract/narrative summary for information regarding the parent grant.